Modular, Chemical-Free Advanced Oxidation of 1,4-Dioxane and its Co-Contaminants in Ground Water

ABSTRACT
The ultimate goal of this remediation project is to design, fabricate, test, and implement point-of-use, small-
scale, water treatment systems that can remove 1,4-dioxane (1,4-DX) and its frequently co-occurring
contaminants, trichloroethylene (TCE), 1,1-dichloroethane (1,1-DCA) and 1,1,1,-trichloroethane (1,1,1-TCA),
from contaminated ground water. The advanced oxidation process (AOP)–the process that employs highly
reactive •OH as main oxidant–is considered to be the most effective among established water treatment
methods for the destruction of these contaminants. However, enabling AOP in a small-scale, distributed
system (i.e., in contrast to centralized large-scale treatment and water delivery through a network of pipe) is
technically challenging due to the requirement for a precursor chemical (such as H2O2) that needs to be
activated on site to produce •OH and the high energy demand.
We will synthesize efficient catalyst materials, engineer various components of the system, and
fabricate two highly-innovative prototype AOP reactors. The first reactor will employ a new catalyst that can
selectively produce high concentrations of H2O2 using only water and oxygen as a source. The produced H2O2
will be activated by another newly-developed catalyst to produce •OH without any external energy/chemical
supplies and without producing undesirable byproducts (which would otherwise require additional treatment).
Coupled together, this catalytic system will enable for the first time AOP of ground water in a small, compact,
distributed water treatment system. The second reactor will employ nanobubble technology. In this system,
ambient air will be introduced to the water in the form of nanobubbles which collapse to produce •OH that will
destroy 1,4-DX. Strategies to enhance the production of •OH through promotion of effective bubble collapse
will be developed. Unlike any existing AOPs, both reactors will not require continuous supply of chemicals. In
addition, they will either be solar powered (completely off-grid) or use a much smaller amount of electricity than
conventional AOPs that employ ultraviolet (UV) irradiation.
We will test the performance of prototype reactors and compare them with benchmark UV/H2O2
process (i.e., adding H2O2 and irradiating UV light). This will involve a comprehensive analysis of the efficiency
of parent compound (1,4-DX) destruction, as well as the evolution of reaction byproducts. Reduction of the
deleterious effects of consuming 1,4-DX-containing water will be investigated in collaboration with Research
Project 1. The prototype reactors will undergo testing in select field sites in Region 1 (identified as being
contaminated by Research Project 2) to determine their efficiency under real world situations and their activity
under long term conditions (employing sensors developed by Research Project 3). By promoting the continual
removal of 1,4-DX and its co-occurring contaminants from drinking water sources, this project will directly
reduce human exposure to these pollutants and thereby limit their adverse health effects.

Public health relevance
NARRATIVE Our overarching goal is to design, fabricate, test, and implement point-of-use small-scale water treatment units that can destroy 1,4-dioxane and its frequently co-occurring pollutants from contaminated ground water through advanced oxidation. Unlike any existing advanced oxidation processes, these reactors will not require continuous chemical supply and will use minimal energy. The prototype reactors will be tested both in the lab and in the field sites in Region 1 in collaboration with other project teams to verify the feasibility of real world use, to confirm the elimination of human toxicity, and to establish faster technology transfer.